Molecular mechanisms of telomere function in muscle stem cells

Project Summary/Abstract
Duchenne Muscular Dystrophy (DMD) is the most common childhood form of muscular
dystrophy and arises from mutations in the dystrophic gene. DMD is characterized by
progressive skeletal muscle degeneration, the presence of focal groups of necrotic myofibers,
muscle hypertrophy and high levels of serum creatine kinase. While
over
focused
the last decade
on treatment
with respect to potential
of skeletal muscle and do
progress has been made
treatments for DMD, current strategies
not take satellite cells into consideration.
are
We
recently demonstrated that telomere shortening is a district feature of dystrophic muscle stem
cells (MuSCs) in both mice and DMD patients already at a very young age. The studies
proposed here will study
determine
stem cells within their native tissue environment of live
the cellular consequence of telomere shortening in MuSCs (Aim 1)
mice
and
will
. This proposal will
also investigate a previously unknown crosstalk between NF-κB and telomeres (Aim 2) and will
determine the function of a telomeric protein in the progression of muscular dystrophy (Aim 3).
Understanding the molecular the link between stem cell functional exhaustion and telomere
shortening will provide potential alternative methods to bypass the use of long-term corticosteroid
treatment currently in use.

Public health relevance
Project Narrative In Duchenne Muscular Dystrophy (DMD) the repeated cycles of muscle damage and repair lead to stem cell dysfunction but current therapies do not target muscle stem cells. The studies proposed here will assess the importance of telomere biology in the progression of muscular dystrophy, using new genetic mouse models that target the stem cell compartment. Our research is aiming to investigate the molecular mechanism of telomere dysfunction in skeletal muscle dystrophy.